Hydrogen Sulfide in Neonatal Airway Disease

ABSTRACT
Moderate (<60%) O2 (hyperoxia) in premature infants promotes bronchial airway hyperresponsiveness (AHR)
via effects on airway smooth muscle (ASM), a cell type that also contributes to impaired bronchodilation, and
remodeling (proliferation, altered extracellular matrix (ECM)). Thus understanding mechanisms by which O2
affects bronchial airways is critical for therapeutic strategies in a vulnerable population. We propose a
protective role for hydrogen sulfide (H2S) in developing airways that can be leveraged in prematurity, thus
providing clinical significance to our proposal. We hypothesize that the protective endogenous H2S system is
detrimentally influenced by O2, but that exogenous H2S donors can be used to counteract detrimental effects of
O2 on contractility and remodeling. Little is known regarding regulation of endogenous H2S in developing
bronchial airways, and mechanisms by which moderate O2 reduces H2S. Conversely, the mechanisms by which
H2S impacts on developing airways to alleviate O2 effects are unknown. We propose 3 Aims using human fetal
lung and in vivo neonatal mouse models of O2 to explore these concepts. Aim 1: In developing human ASM,
determine influence of O2 on endogenous H2S; Aim 2: In developing human ASM, determine mechanisms by
which H2S alleviates O2-enhanced airway contractility and remodeling; Aim 3: In a newborn mouse model of
hyperoxia, determine effects of H2S on airway contractility and remodeling. In Aim 1, we will use 18-22 wk
gestation human fetal ASM (fASM) to examine mechanisms by which O2 decreases H2S, focusing on ROS,
mitochondria, and alterations in the methionine-transsulfuration balance that can drive changes in the H2S
synthesis enzyme CBS. Aim 2 explores downstream effects of H2S (via donors NaHS and GYY4137, and
enhancement of endogenous H2S) in the context of contractility and remodeling following 40% O2. Here, the
focus is on three key mechanisms: suppression of HIF1α, activation of Nrf2, and enhancement of cAMP. In Aim
3, in vitro studies are integrated using a newborn mouse model of hyperoxia where early exposure to moderate
oxygen levels results in sustained AHR and remodeling. The efficacy of H2S donors in alleviating AHR and
remodeling is assessed. Clinical significance lies in establishing the importance of H2S in O2 effects on
developing airway towards future therapeutic targeting for neonatal asthma.

Public health relevance
NARRATIVE Babies born prematurely who are exposed to oxygen in the neonatal intensive care unit are at increased risk of airway diseases such as asthma, which makes it important to understand how oxygen detrimentally impacts the developing airways. The goal of this proposal is to use human cell and mouse models to investigate a novel, targetable mechanism (hydrogen sulfide) that we believe is normally protective in developing airways and can help to reduce the reactivity and fibrosis that occurs with oxygen exposure (thus reducing asthma in babies and children). The importance of our work lies in the potential application of novel drugs that can enhance hydrogen sulfide for improving airway function in preterm infants and reduce the risk of developing asthma later in life.